Administrative Core

PROJECT SUMMARY
The Administrative Core of the UTRGV Diversity Center for Genome Research is designed to provide the
administrative support required for the Center to enhance institutional genomics research capacity and the
genomics research environment at UTRGV. The Core will help to facilitate collaborative and independent
research projects across the different units of the university by leveraging institutional and national resources,
and to expand research capabilities to conduct cutting-edge genomics science, with an emphasis on studies in
populations experiencing health disparities. The Administrative Core will provide leadership, coordination,
administrative oversight, and financial management to the Center through implementation of a comprehensive
management plan. It also will implement an evaluation plan to assess Center activities and determine the impact
of the Center on 1) enhancing institutional infrastructure and the research environment at UTRGV to facilitate
genomic research; 2) increasing the productivity of investigators as determined by peer reviewed publications
and genomic discoveries; and 3) increasing UTRGV’s overall success in applying for and obtaining extramural
research funding. These comprehensive assessments will facilitate continuous refinement and improvement of
Center programs in order to enhance investigator and trainee satisfaction with the Center. A complementary
approach to continuous quality improvement will be obtaining advice from Advisory Committees and the Steering
Committee. The Center will have both an Internal Advisory Committee and an External Advisory Committee that
will conduct regular reviews of progress in the Center and make recommendations regarding the approaches
and activities of the Center. In order to maximize the impact of the Center, the Administrative Core will facilitate
participation in national genomics consortia, including the consortium of NHGRI Diversity Centers. Center
investigators already participate in TOPMed, T2D Genes, ENIGMA, WGSPD, and AMP T2D Genes. The
Administrative Core will use a variety of approaches to communicate with the scientific and local communities
about opportunities available through the Center and progress made by the Center, including an annual
Genomics Research Symposium and an annual Texas Mexico Research Collaboration Colloquium. The
Administrative Core will be responsible for implementing the Plan for Enhancing Diverse Perspectives. Through
its varied activities, the Administrative Core will work to ensure the success of the UTRGV Diversity Center for
Genome Research.